Role of ZNF proteins in the establishment and maintenance of HIV latency

Title: Role of ZNF proteins in the establishment and maintenance of HIV latency
Abstract
Antiretroviral combination therapy against the human immunodeficiency virus (HIV) infection has significantly
prolonged the life span of people living with HIV, transforming viral infection into a chronic condition with
undetectable viral loads. However, a complete cure against HIV is still out of reach, as a pool of infected
reservoir cells carrying a transcriptionally silent, yet replication-competent virus persists. Within these
reservoirs, infected cells do not express viral proteins, and were until recently regarded to be protected from
host immune responses. However, new single-cell analytic techniques revealed that this pool of infected cells
displays discrete footprints of immune selection, implying that human immune responses effectively
recognize at least some of them. In particular, genome-intact HIV preferentially persists in ZNF genes that
impose proviral transcriptional silencing through the recruitment of transcriptional repressors that induce
epigenetic heterochromatin markers. The central hypothesis of this study is that ZNF proteins have
pivotal functions in establishing and maintaining the HIV-1 reservoir by silencing proviral
transcriptional activity and protecting HIV-1 genomes from antiviral immune recognition. To validate
this hypothesis, Aim 1 proposes to evaluate the role of ZNF proteins in changing the epigenetic landscape
in primary CD4+ T cells. By employing CRISPR-CAS9, we will modulate the expression of selected ZNF
genes in primary CD4+ T cells, and use well-established tools to assess the genome-wide epigenetic
changes in the context of ZNF depletion. We expect to demonstrate that HIV-1 selectively persists at
chromosomal locations that are susceptible to ZNF protein-dependent gene silencing through recruitment of
heterochromatin markers. Aim 2 will then explore mechanisms of HIV-1 latency reversal through inhibition
of ZNF proteins in CD4 T cells from participants living with HIV. We will use single-cell assays to investigate
changes in proviral gene transcription following depletion of selected ZNF genes, applying tools permitting
simultaneous assessments of HIV-1 transcription and integration. Based on these findings, specific
pharmacological approaches that will target ZNF proteins may be developed that might help to eliminate the
viral reservoir by increasing its immunological vulnerability.
1

Public health relevance
Narrative HIV reservoir cell persist lifelong despite antiretroviral therapy, and represent the main barrier to a cure of HIV-1 infection. Here, we will test the hypothesis that ZNF proteins can repress the transcriptional activity of HIV-1 proviruses through the recruitment of heterochromatin markers to proviral integration sites. 2